Open Platform for Online Simulations for Stimulating Peripheral Activity to Relieve Conditions - o2S2PARC

o2S2PARC Y6 Abstract for NIH RePORTER
IT’IS Foundation, SIM-Core
SIM-Core’s mission is to ensure that the computational models and analyses developed under the SPARC program are accessible, sustainably preserved, reusable, and interoperable. To this end, a comprehensive, user-friendly Open platform for Online Simulations for Stimulating Peripheral Activity to Relieve Conditions (o2S2PARC) has been developed. o2S2PARC enables computational models and analyses to be published as reusable building blocks (‘services’) in larger pipelines and workflows that can be shared and accessed via common web browsers and executed in the cloud. Workflows created by expert modelers can be packaged as easy-to-use applications using o2S2PARC’s ‘Guided Mode’ to provide, for example, a treatment-planning tool that can be used by clinicians with little modeling expertise. Close interaction with other SPARC teams allows continuous adaption of the platform design to facilitate integration and coupling of new models. To date, o 2S2PARC has provided many dozens of services developed by SPARC researchers and SIM-Core to facilitate tasks such as image processing and image-based modeling, mechanistic and data-driven biophysical simulation (electromagnetic, electrophysiology, organ physiology, etc.), training and application of deep neural networks, parameterized modeling, and explorable data analysis and visualization. o2S2PARC provides access to detailed whole-body anatomical models and enables biophysiological simulations within realistic representations of the anatomical environment. The ultimate goal of o2S2PARC is to enable modeling of bioelectronics medicine applications, from device-level physical interactions with the peripheral nervous system/spinal cord through to the resulting therapeutic effects on organ physiology, while also providing advance warning of potential unwanted side effects. Developers benefit from powerful application programming interfaces, e.g., for setting up and running complex simulations using the computational resources provided by SPARC. IT’IS is committed to maintaining the o2S2PARC platform and developing a sustainability plan beyond the SPARC program. In the coming months, the IT’IS team will continue to harden and increase stability and scalability to accommodate increased use. Integration with the SPARC data, maps, and knowledge management will be tightened, and a dedicated effort will be made to increase the attractiveness of o2S2PARC and other SPARC resources to application developers.

Public health relevance
No Text